Improving the design and implementation of school-based oral health programs using secondary data analysis

PROJECT SUMMARY
Dental caries is the world’s most prevalent noncommunicative disease and negatively impacts child
development. Both the NIDCR Oral Health in America report and the World Health Organizations’ Global Oral
Health Status report call for improved access to and delivery of effective preventive oral care across the
lifespan. School-based caries prevention can increase access to critical care for underserved children,
reducing caries risk and mitigating its severe health and socioemotional consequences. The CariedAway study
was a longitudinal pragmatic randomized trial of novel approaches to prevent and control dental caries in a
school-based program, with a particular focus on low-income children. Previous findings from CariedAway
demonstrated that (1) silver diamine fluoride (SDF) is equivalent to dental sealants and atraumatic restorations
in the arrest and prevention of dental caries; (2) SDF can be effectively provided by school nurses, who are
comparable to dental hygienists; and (3) treatment with SDF for caries prevention and control resulted in
improved oral health-related quality of life. These findings support the large-scale utilization of SDF for school-
based caries prevention, especially in severely under-resourced areas. In this R03 proposal we will conduct
secondary analysis of the CariedAway data in order to support the wider implementation of silver diamine
fluoride into school-based caries prevention. We will first explore the longitudinal arrest capabilities of school-
based SDF in greater detail, including the additive effect of repeat application, the effect of posterior application
on anterior caries incidence, and the transition probabilities between sound, carious, and arrested states.
Second, we will estimate the surface-level risks of dental caries following treatment with SDF, modified by the
severity of baseline disease. In this analysis, we will account for interval-censoring that occurs in school-based
care using semi-parametric G-estimation. Finally, we will estimate the overall treatment time required for SDF
in a school-based model and compare it to the time required for similar application of dental sealants and
atraumatic restorations. The proposing investigators possess relevant, complementary expertise to ensure the
success of this project: the PI is an epidemiologist and education researcher focusing on school-based care
and was a Principal Investigator of the CariedAway project. The Co-I is a public health dentist with expertise in
dissemination and implementation research, and was previously the Director and Supervising Dentist of the
CariedAway project.

Public health relevance
PROJECT NARRATIVE Dental caries is the most prevalent childhood disease in the world and disproportionately affects low-income children in urban and rural areas. CariedAway was a randomized trial that demonstrated that silver diamine fluoride (SDF) is equivalent to sealants and atraumatic restorations in the prevention and control of caries in school oral health programs. This project proposes to conduct secondary data analysis of CariedAway study data to better inform the large-scale implementation of SDF for school-based caries prevention.